MATURATIONAL PROTEASE OF HERPES SIMPLEX VIRUS

The herpes simplex virus (HSV) moustional protease (UL26 gene product) is involved in formation of the virus capsid. Numbers of different structures are seen in the in vitro assembly system. A mutant of the protease, protein 61, seems to make structures by itself This protein was examined in the STEM and had a very heterogeneous distribution of sizes.